The Roybal Center for Therapeutic Optimization using Behavioral Science

The evidence-based use of prescription medications has led to substantial improvement in healthy aging.
Despite this, the use of medications by patients and providers remains suboptimal. Many patients are not
prescribed guideline-recommended therapies from which they would benefit; among those for whom
appropriate treatment is initiated, almost half do not adhere over the long-term; and others receive potentially-
hazardous medications with an unfavorable balance of risks and benefits. The result: preventable adverse
health outcomes and health spending for middle-aged and older adults.
While many factors influence the suboptimal use of prescription medications, individual, interpersonal and
institutional behaviors are central. As a result, existing intervention to address these issues have attempted to
remind, reward, motivate, simplify or otherwise change behavior. Unfortunately, these approaches have only
been modestly effective and even among those do work, behavior change is rarely sustained over the long-
term. The results can be explained by the lack of integrating behavioral principles when designing
interventions, a limited focus on evaluating how to deliver them over the long term, and the inherent challenges
in delivering precise and personalized behavior change at population scale.
Thus, the Brigham and Women’s Hospital Roybal Center for Therapeutic Optimization using Behavioral
Science will continue to focus on the thematic area of promoting adherence and maintenance of long-term
behavior change. The structure and activities of the proposed Center will be based upon 4 key principles: (1) a
multi-disciplinary approach; (2) the testing of principle-driven interventions in real-world settings; (3) the explicit
testing of mechanisms of action, and (4) the use of novel analytic methods and technological approaches to
gain a deeper understanding of behavioral mechanisms and to personalize interventions. Based on these
principles, our Center will have the following Specific Aims:(1) to oversee a translational research program for
the testing of principle-driven, potent, practical, scalable and sustainable behavioral interventions to enhance
the appropriate prescribing and use of evidence-based medications.; (2) to strategically direct and to provide
scientific oversight, fiscal and operational support to ensure the successful completion of behavioral
interventions funded by the Center.; and (3) to conduct trials evaluating principle-drive interventions that aim to
sustain behavior change for the use of evidence-based medications. The proposed Year 1 studies conducted
in partnership with large delivery systems and testing novel approaches to promote the deprescribing of high-
risk medications and to support adherence to evidence-based preventive therapies.
The expected impact of the Roybal Center for Therapeutic Optimization using Behavioral Science is that it
will develop principle-driven interventions that will readily translate to improvements in healthy aging and will
also advance our fundamental understanding of how health behaviors can be effectively sustained.

Public health relevance
The overarching goal of the Brigham and Women’s Hospital/Harvard Medical School Roybal Center for Therapeutic Optimization using Behavioral Science is to continue to develop principle-driven interventions to enhance the evidence-based use of prescription medications. The structure and activities of the proposed Center will be based upon 4 key principles: (1) a multi-disciplinary approach; (2) the testing of principle-driven interventions in real-world settings; (3) the explicit testing of mechanisms of action, and (4) the use of novel analytic methods and technological approaches to gain a deeper understanding of behavioral mechanisms and to personalize interventions. The principle-driven interventions developed by our Center will readily translate to improvements in healthy aging and will also advance our fundamental understanding of how health behaviors can be effectively sustained.